Developmental Core

PROJECT SUMMARY
THIRD COAST CFAR CORE B: DEVELOPMENTAL CORE (DC)
The Third Coast Center for AIDS Research (TC CFAR) Developmental Core (DC) serves as the foundation from
which members build new NIH-funded research that advances the Administrative Core (AC)-prioritized scientific
agenda. DC services enable and fuel each of the TC CFAR Overall aims. The DC provides a range of seed
funding mechanisms for all faculty (Core Subsidy Awards), faculty new to HIV research (Pilot Awards), our
scientific Cores (Core Resource Awards), and community partners (Community Collaborative and Community
Mini-Awards). DC has enabled success in competitions for administrative supplements (AS) and assists AC with
other mechanisms. In the first 5 years, more than $5.6 million was awarded via multiple DC mechanisms and
AS, with >$860,000 of that total contributed by NU and UC from institutional support. In less than 5 years, returns
on these investments have been strong. Projects on each of the 3 Overall aims have been funded by DC Awards
and Administrative Supplements; Overall aims 2 and 3 emerged from AC-led strategic planning more recently
than Overall aim 1. DC work proposed here adds to anticipated growth in DC-funded projects addressing Overall
aims 2 and 3. New entrants to HIV research, and trans-disciplinary submissions to the DC, have increased.
Community Collaborative Awards built relationships with HRSA-funded community partner organizations that,
along with learning from processes for Administrative Supplement proposal development, enabled a strong
response to the Ending the HIV Epidemic (EHE) Initiative and the successful launch of new EHE Scientific
Working Group that is starting to seed more research-practice partnerships. Strong mentorship is another DC
service that contributes to junior faculty career development, is growing HIV research at University of Chicago,
and starting to improve representation of URM faculty across the CFAR. A new cross-institutional and cross-
disciplinary NHLBI-funded career development program (Third Coast HIV-related Cardiovascular and Sleep
Disorders K12 Career Development Program) is synergizing future growth of non-AIDS co-morbidities research
as well as our faculty’s careers. Junior faculty gain DC review panel experience, and the Core will now also
mentor a new co-director and give junior faculty achieving independent NIH funding leadership experience as a
rotating co-director. The DC also navigates CFAR members to resources that enhance proposal and project
development, including mentoring before and after DC submissions and mock study section reviews prior to NIH
submissions. The aims of this renewal are: (1) to provide seed funding to TC CFAR members, emphasizing early
stage investigators (ESI) and established faculty new to HIV research, to further enhance high priority HIV
research; (2) to inform and fund current and new community partners providing public health, prevention, and
care services, including those countering structural inequities driving the HIV epidemic; (3) to enhance career
development, and improve navigation to proposal-enhancing expertise for new entrants to HIV research and our
scientific priorities.